Promoting stress-resilience prevents AD-associated neuropsychiatric symptoms

PROJECT SUMMARY
Alzheimer's disease (AD) is commonly associated with social behavioral abnormalities and
neuropsychiatric symptoms (NPS). In fact, NPS are increasingly recognized as core features of AD. However,
research in AD has been primarily focused on the diagnostic and therapeutic treatment of memory deficits.
There is an urgent need to better understand the neurobiology, behavior, and underlying mechanisms of NPS
in AD. In response to PAR-23-207, we propose to investigate the influences of individual vulnerability to
stress on the expression of NPS syndromes in mouse models of AD and to test the hypothesis that
promoting stress resilience could prevent or delay the future emergence of AD-associated NPS.
Stress is a major risk factor for neuropsychiatric disorders. In mice, we found that stress-susceptible
(SUS) mice exhibit a spectrum of social, motivational, and reward deficits that are similar to the NPS, such as
apathy, anxiety, and social withdrawal in human AD. We established that stress-susceptibility is associated
with aberrant microglia activation in the prefrontal cortex (PFC) and, in turn, disrupts PFC neurophysiological
properties. Moreover, gene expression analysis in the PFC of SUS mice showed several differentially
expressed genes resembling those of disease-associated microglia (DAM) found in AD. Critically, stress-
resilient mice maintain healthy-like PFC neurophysiological properties and healthy-like microglia activity. Our
data shows that by manipulating microglia activity during stress exposure, we prevented stress-induced
anhedonia and social withdrawal. Based on these observations, we hypothesize that vulnerability to prior
stress exposure, stress-SUS, may prime PFC microglia in the PFC and promote the initiation and progression
of AD-associated NPS behavioral and neuronal deficits, and oppositely, the active resilient mechanisms of
stress-RES individuals, could prevent or delay AD-associated NPS and neuronal deficits.
Using the 5xFAD and the 3xTg mouse models and leveraging two different stress paradigms: chronic
social defeat stress and chronic variable stress, we propose to promote stress-resilience and to assess its
short-term and long-term impacts on 1) NPS-like behavior development; 2) cortical neuronal activity and
molecular underpinnings, and 3) circuit-connectivity associated with NPS-like phenotypes. To account for sex
as a biological variable, we will characterize molecular, electrophysiological, and behavioral responses to
stress, and AD-type NPS predispositions in female and male mice. We will employ cutting-edge methodology
from cognitive and affective neuroscience and integrate multiple levels of analysis to address neurobiological,
behavioral, and molecular mechanisms. These studies will uncover the active resilient mechanism(s) in the
brain and offer novel targets for the prevention and treatment of NPS in the context of AD.

Public health relevance
PROJECT NARRATIVE Chronic stress is a major risk factor for Alzheimer's disease (AD) and associated neuropsychiatric symptoms (NPS), yet most studies have treated stress response as a uniform construct and overlooked the individual differences observed in humans. Preclinical research has mainly focused on memory function and much less on the neuronal trajectory encoding NPS. In this study, using AD transgenic mice, we propose to test the hypothesis that stress-resilient individuals, through active mechanisms, control microglia cortical functions and actively reduce the impact of chronic stress on the emergence of AD-associated NPS.